INTRATHECAL HUMORAL RESPONSES AND DEVELOPMENT OF SIV M-TROPIC VARIANTS IN CNS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. Sustained SIV infection of the CNS depends on macrophage-tropic (M-tropic) strains that are often easily neutralizable. Concomitantly, the CNS is often thought of as an immunologically privileged site that fosters replication of M-tropic quasispecies. Yet, there are limited data addressing the intrathecal antibody response or the role of the humoral response in general to control M-tropic strains. We investigated the temporal course of the intrathecal neutralizing activity and found an inverse relationship between the magnitude of neutralization and the prevalence of M-tropic populations. These studies suggest a role for the humoral response in the suppression of M-tropic viral species in the CNS in experimental SIV infection.